PROCYSTEINE IN PATIENTS INFECTED WITH HIV--EFFECTS ON LEVELS OF GLUTATHIONE

Phase I, dose-ranging study to determine safety, tolerability and pharmacokinetics of glutathione after the acute and chronic administration of procysteine to HIV positive adults.